The University of Kentucky Division of Regulatory Services (UKDRS) continued development of a risk-based Animal Feed Inspection Program

Project Summary
The University of Kentucky Division of Regulatory Services (UKDRS) achieved full
implementation and conformance to the Animal Feed Regulatory Program Standards
(AFRPS) in August of 2019. Moving forward, UKDRS requests continued funding
support to continue full conformance with the AFRPS, to maintain an integrated animal
feed safety system, and to advance the cooperative agreement with FDA. It is the goal
of the UKDRS to be an effective component of an integrated animal feed safety system
within the United States. Multiple activities will be supported through this project
including continued funding for our AFRPS Coordinator, training, travel, feed sampling
activity, conducting complaint investigations, and conducting animal feed manufacturer
inspections.

Public health relevance
Project Narrative: The University of Kentucky Division of Regulatory Services (UKDRS) achieved full implementation and conformance to the Animal Feed Regulatory Program Standards (AFRPS) in August of 2019. Moving forward, UKDRS requests continued funding support to continue full conformance with the AFRPS, to maintain an integrated animal feed safety system, and to advance the cooperative agreement with FDA. It is the goal of the UKDRS to be an effective component of an integrated animal feed safety system within the United States. Multiple activities will be supported through this project including continued funding for our AFRPS Coordinator, training, travel, feed sampling activity, conducting complaint investigations, and conducting animal feed manufacturer inspections.